Comparative Genomics and Bioinformatics Core

Comparative Genomics And Bioinformatics Core
SUMMARY/ABSTRACT
The Comparative Genomics and Bioinformatics (CGB) Core will provide state-of-the-art comparative genomic
and bioinformatic analyses, and data warehousing to support the overarching goal of the P01 to improve our
understanding of endometriosis disease pathophysiology in women and provide a foundation for improving
treatment. The scientific premise that evolutionarily conserved genomic features inform function is well-
established. An innovative aspect of the Core is the use of comparative genomics in humans, monkeys and
mice, including transcriptomics and epigenomics, to identify evolutionarily conserved pathways central to
endometriosis pathophysiology. The CGB Core has 4 Specific Aims to support the overall goals of the P01: 1)
Identify transcriptional pathways and networks associated with disease status in women (Projects 1&2), mice
(Project 2), and rhesus macaques (Project 3); 2) Integrate transcriptome data with epigenome (chromatin) and
metabolome data generated in the Projects to prioritize pathways and causal networks most likely to have
regulatory roles in disease status; 3) Identify disease-associated genes, pathways, and causal networks that are
conserved among the three species; and 4) Provide a data warehouse for organizing and sharing data generated
in the CGB Core and the Projects, and comply with NIH data sharing requirements. The Core Leader Dr. Cox
has extensive comparative genomic expertise that includes studies with marsupials, rodents, nonhuman
primates, and humans. All methodologies, analysis tools, and data management practices proposed for the Core
are routinely used and well-established in the Core Leader’s laboratory, supporting success of the CGB Core to
achieve these aims. Successful completion of these aims will reveal molecular pathways and networks
associated with disease status for each species and, by identifying those conserved among humans, mice and
rhesus, will nominate regulators that are central to the disease process. Achieving these goals will contribute to
a better understanding of the disease process which will inform diagnosis and treatment for long-lasting
improvement in the lives of women suffering from endometriosis.